Administrative Core

IN-TRAC ADMINISTRATIVE CORE ABSTRACT
The Administrative Core is responsible for administrative and scientific leadership for IN-TRAC and is
responsible for coordinating all communication between IN-TRAC Cores, researchers and NIH/NIAID Program
staff; oversight of all IN-TRAC activities; and providing an organizational and administrative structure to optimize
opportunities to promote multidisciplinary collaborations and interactions between the Cores and among a
diverse cohort of IN-TRAC trainees. AIM 1: Oversight of all administrative activities to monitor progress
towards IN-TRAC milestones. Working within a well-defined organizational structure, the Administrative Core
will establish a schedule for Core Director meetings to review progress towards milestones, review challenges
and opportunities, and core budget updates. The Administrative Core also has responsibility for assuring
compliance for animals, humans subjects, biosafety, and responsible conduct of research in conjunction with the
other Cores. AIM 2: Implement quantitative and qualitative measures and programmatic interval
assessments to ensure progress toward IN-TRAC milestones. The Administrative Core will form an IN-
TRAC External Advisory Board, in consultation with NIH/NIAID, to annually evaluate progress of IN-TRAC. The
Administrative Core will also develop and implement internal quantitative and qualitatively measures and
programmatic milestones to monitor progress towards goals. AIM 3: Provide oversight of IN-TRAC to ensure
integration with the Institutional Strategic Plan. The Administrative Core Director will communicate IN-TRAC
goals and progress to institutional leaders and evaluate the program in the context of the Institutional Strategic
Plan to ensure continuous institutional alignment. The Administrative Core Director will liaise with the Executive
Vice President, Research (EVPR), the Southwest National Primate Research Center (SNPRC) Director, and
Scientific Program Leads to promote the integration of the IN-TRAC program into broader institutional
programming. The President &CEO, EVPR, and SNPRC Director are all established TB researchers.